A harmonized vendor-agnostic environment for multi-site functional MRI studies

Since its invention in the early 90s, functional magnetic resonance imaging (fMRI) has revolutionized our un-
derstanding of the human brain. Functional MRI may be used to observe brain function during a speciﬁc motor
or cognitive task, or at “rest” (resting-state fMRI). The latter produces so-called “functional connectivity” maps
that may provide a new window into human cognition. There is currently a large, world-wide effort underway
to discover potential research and clinical uses of such connectivity maps. A signiﬁcant practical barrier in this
effort, however, is the difﬁculty in ensuring that fMRI experiments are conducted in a consistent and reproducible
manner across different centers. In particular, it is generally not possible to ensure identical execution of MR
measurements (pulse sequences) across sites operating different MR scanners. Furthermore, even the image
reconstruction and data processing methods can be difﬁcult to harmonize, particularly across different MR ven-
dors. This makes it challenging to directly compare results between sites, or “pool” data from multiple sites to
increase statistical power and gain access to rare clinical conditions.
We will assemble and disseminate a truly harmonized, cross-vendor, and ﬂexible environment for fMRI re-
search that ensures consistent data acquisition and image reconstruction across sites. Our framework is based
on an open-source MR sequence development platform that allows any arbitrary MR pulse sequence to be de-
signed “off-line” in Matlab or Python and exported to a vendor-independent ﬁle format, that can be ported directly
to scanners from different manufacturers (at present, General Electric and Siemens are supported, but others
may follow in the future). Due to this open pulse sequence structure it will also be possible to compose a uniﬁed
image reconstruction environment based on current open-source libraries. Based on this technology, we will
provide the fMRI research community with a complete and portable workﬂow for fMRI data acquisition and image
reconstruction, backed up by integrated quality control procedures.

Public health relevance
The advent of functional magnetic resonance imaging (fMRI) has revolutionized our understanding of human cognition. Unfortunately, it is nearly impossible to ensure identical execution of fMRI experiments across different MRI scanners due to subtle differences in how MRI scanners from different vendors implement fMRI protocols, leading to challenges in interpretation or pooling results from different fMRI centers. This project will establish and distribute a software environment to help fMRI researchers achieve consistent results across sites and scanner models.